CORE--BIOSTATISTICS FACILITY

Biostatistics Core of the present Program Project proposal serves to provide biostatistical collaboration to the investigators individually and collectively. The Biostatistics Core will provide services regarding data collection, retrieval, and biostatistical analysis to the Cores and the individual research components.